Catalytic Oxidations for Pharmaceutical Synthesis

Project Summary
Oxidation reactions are among the most important reactions in organic chemistry and play a crucial role in
the synthesis of pharmaceuticals, natural products, and other bioactive compounds. Advances in catalytic
oxidation reactions have potential for major impact in the discovery and production of pharmaceuticals. The
majority of existing catalytic oxidation methods face challenges in their efficiency and selectivity, including
chemo-, regio- and stereoselectivity, limiting their use in small- and large-scale applications. The proposed
research will develop new oxidation and oxidative coupling methods that form carbon-carbon and carbon-
heteroatom bonds, including C(sp3)–H functionalization reactions. Some of the resulting methods will
streamline the discovery of new bioactive molecules with diverse three-dimensional architectures, addressing
key challenges in medicinal chemistry and drug discovery, while others will provide the basis for streamlined
process-scale synthesis of pharmaceuticals. Three complementary project directions are outlined in this
proposal. The first focuses on the development of "oxidase"-type aerobic oxidation catalysts that feature a
transition metal and a redox active organic co-catalyst. New bioinspired catalyst systems will be explored that
exhibit "second-order biomimicry", whereby simple organic precursors undergo oxidative self-processing to
create the essential co-catalysts. This process resembles the post-translational modification of amino acid
side chains to generate reactive cofactors in Nature. The second project will pursue new electrochemical
oxidation methods for the synthesis of organic molecules that are difficult to access via classical synthetic
methods. These efforts target the design of mediators and electrocatalysts that permit the reactions to
proceed at low electrode potentials, thereby tolerating diverse functional groups and enabling broad scope
and utility. Finally, we will develop "radical relay" methods for benzylic C–H oxidation and oxidative coupling
to afford new C(sp3) C–O, C–N, C–X, and C–C bonds. These efforts will be applied to pharmaceutical building-
block diversification, core-modification, and late-stage functionalization. In each of these project areas,
empirical reaction discovery efforts will be complemented by mechanistic studies of the catalytic reactions.
Close interactions and collaborations with pharmaceutical companies in all phases of this project will play an
important role in ensuring the broadest possible impact of our efforts. Each of these project areas is supported
by rigorous kinetic and mechanistic analysis that will greatly benefit from dedicated equipment designed to
monitor the reaction progress.

Public health relevance
Project Narrative Selective oxidation of organic molecules represents one of the key reaction classes available for the synthesis and discovery of pharmaceutical intermediates and therapeutic agents. Our research focuses on developing a broad range of new oxidation methods that achieve selective formation of new carbon-carbon and carbon- heteroatom bonds.